Structure function investigations of radical transfer and disulfide exchange in a class Ia ribonucleotide reductase

PROJECT SUMMARY/ABSTRACT
Class Ia ribonucleotide reductases (RNRs) are anti-cancer and antibiotic drug targets due to their role in the
biosynthesis of deoxyribonucleotides. They convert ribonucleotides to deoxyribonucleotides using radical-
based chemistry with reducing equivalents coming from a pair of cysteine residues in the active site that form a
disulfide upon enzyme turnover. Recent structural work elucidating the active state structure of the class Ia
RNR of Escherichia coli has revealed for the first time, the intact 32-Å-long pathway for radical transfer
between subunits that is responsible for the generation of a catalytically essential radical species in the
enzyme active site. In this proposed research, I will investigate the role of water channels in the proton transfer
that occurs concomitant with electron transfer. I will also investigate the role of a tryptophan residue (W48) in a
radical transfer pathway that otherwise involves tyrosine residues. Furthermore, I will probe the structural
rearrangements that occur in order to facilitate re-reduction of the active site disulfide. This re-reduction
pathway is known to be dependent on the C-terminal tail of the α subunit of RNR, which shuttles reducing
equivalents from thioredoxin to the active site, but no structural snapshots of this process have ever been
captured. Here, I propose to use site-specific mutagenesis to investigate the involvement of water channels in
proton transfer by assessing the catalytic competency of RNR variants in which the water networks have been
disrupted. I intend to assess the role of W48 in the PCET pathway through the site-specific incorporation of
unnatural W analogues which will give us a spectroscopic handle with which to directly monitor radical transfer
to and from W48. Finally, I propose to capture structural snapshots of the re-reduction steps of RNR, including
a structure of RNR with thioredoxin using cryogenic electron microscopy. These studies will enable us to
answer several of the major outstanding questions of this prototypical RNR. This work will also enable me, a
physical inorganic and materials chemist by training, to gain expertise in biochemical and structural biology
methods which will inform new research directions that will benefit from a synthesis of these two skill sets. As
one of the world’s foremost research institutions, MIT is an ideal and highly collaborative environment in which
to pursue the studies described in this proposal. Furthermore, as an internationally recognized leader in the
field of structural biology, Prof. Drennan’s scientific mentorship will enable me to excel in my undertaking of this
research.

Public health relevance
PROJECT NARRATIVE Ribonucleotide reductase (RNR) is an essential enzyme and is responsible for the reduction of ribonucelotides into deoxyribonucleotides for use in DNA biosynthesis. For this reason, an understanding of the chemical and structural mechanisms of RNR catalysis are crucial for informing our efforts to develop novel anti-cancer and anti-pathogenic drugs. A recent breakthrough in elucidating the structure of the active state of the E. coli class Ia RNR has enabled us to revisit many of the remaining questions regarding the catalytic mechanism of this prototypical RNR. Here, we propose to use this unprecedented structural snapshot to inform our efforts to answer several critical outstanding questions regarding the proton-coupled electron transfer pathway and the re-reduction mechanism of RNR via site-directed mutagenesis studies and using structural techniques such as crystallography and cryogenic electron microscopy.